Development of Multidimensional, Linear and Differential Ion Mobility MS Separations for Middle-Down Proteoforms

Project Summary PI: Francisco Fernandez-Lima This equipment supplement application requests funds to purchase a LEAP HDX Base System, and corresponding HDExaminer Data Analysis Software to support instrumental advances in tandem ion mobility ? mass spectrometry (IMS/IMS-MS/MS) with the goal of providing needed complementary structural information to the middle-down and top-down strategies developed for the structural characterization of DNA binding proteins and ligand interaction dynamics under the aims of the PI’s NIGMS active grant R01-GM134247. This equipment supplement request will also streamline the application of solution HDX technology in tandem with unique middle- down and top-down IMS- MS strategies for several active-funded NIGMS investigators at FIU via the Advance Mass Spectrometry Facility, directed by the PI.

Public health relevance
Project Narrative PI: Francisco Fernandez-Lima This supplement application requests funds to purchase a a LEAP HDX Base System and corresponding HDExaminer Data Analysis Software to support instrumental advances in IMS/IMS-MS/MS under the aims of the PI’s NIGMS active grant R01-GM134247 with the goal of providing needed complementary structural information to the middle -down and top-down strategies developed for the structural characterization of DNA binding proteins and ligand interaction dynamics.